The NEW Biology Workbench

DESCRIPTION (provided by applicant): Biomedical research has become increasingly dependent upon software and visualization tools to analyze gene and protein sequences. Providing a proper information technology support environment to analyze sequences and store the data produced is essential, but often presents a particular challenge to researchers who have conducting "wet lab" investigations as their main goal. At present, 28,000 researchers and students depend on the Biology Workbench (workbench.sdsc.edu) to meet their needs for sequence analysis software, data storage, and data retrieval. The Biology Workbench provides users free access to web-based environment where users with only an internet browser can conduct analyses, access databases, and store their results. Users have access to 80 sequence analysis functions and 33 remote databases of international significance, and a storage allocation for their personal data. The user base of the Biology Workbench has now grown larger than the original architecture of the Biology Workbench can support, and its rate of growth remains constant. This proposal outlines a methodology to refractor the existing Biology Workbench to create a more modular, more stable platform to meet the needs of Molecular Biologists for analytical tools, databases, and an area to store the results of their work. In its refactored form, the Next Generation Biology Workbench created under this funding will remove the limitation on number of users, create an easily expansible, reusable structure into which community codes can be mounted. It will provide users access to all currently available Workbench tools, and a variety of new enabling technologies, including visualization tools, Web Services, a user configurable interface, peer-to-peer data sharing capabilities, and grid computing capabilities. The proposal outlines a well defined methodology for creating and evolving the software created under this proposal to ensure that it meets the needs of its user base. It also describes a methodology for expanding the user base into new communities.